Revealing the neural mechanisms of amygdala-striatal control of stress-induced habits

The brain has two strategies for behavioral control. Goal-directed actions that rely on prospective
consideration of their outcomes and consequences, and habits, reflexive responses performed without
forethought of their consequences. Overreliance on habit contributes to maladaptive perseverative behavior,
which characterizes numerous psychiatric conditions, including autism. Environmental factors, like chronic
stress, and genetic alteration, can tip the balance between actions and habits. However, our knowledge of the
brain mechanisms by which these factors influence habits is lacking, limiting our understanding of maladaptive
behaviors in psychiatric conditions, and how to treat them effectively. Therefore, the broad goal of my research
is to reveal specific neuronal mechanisms that allow genes and the environment to modulate behavioral control.
Accumulating evidence suggests the dorsomedial striatum (DMS) is central for controlling goal-directed
actions. Inhibition of the DMS, particularly Drd1+ direct pathway neurons, disrupts goal-directed control, resulting
in a bias toward habits. The basolateral amygdala (BLA) is a known hub for stress-responsivity in the brain and
projects onto DMS Drd1+ neurons. My postdoctoral work has revealed that BLA-DMS activity supports goal-
directed learning and is suppressed after chronic stress exposure. Further, I found that activation of BLA-DMS
projections in stressed animals is sufficient to restore goal-directed control. This led me to the intriguing
hypothesis that chronic stress dysregulates DMS Drd1+ control of goal-directed learning via BLA-DMS input.
Through the proposed research, I will reveal how chronic stress changes the DMS Drd1+ neuronal activity
associated with goal-directed learning, at the population and single-cell levels, and how BLA input facilitates this.
I will accomplish this using cellular resolution in vivo calcium imaging with miniscopes, combined with projection-
specific chemogenetic manipulation, in mice (Aim 1; K99). In my independent phase, I will apply these techniques
to a mouse model of 16p11.2 microdeletion, a genetic alteration associated with autism and that is known to
dysregulate striatal function. Specifically, I will examine the vulnerability to premature habits of 16p11.2 mice,
normally and after stress, and assess amygdala-striatal control, using cell-type specific in vivo calcium imaging
with miniscopes, slice electrophysiology, and projection-specific optogenetic manipulations (Aim 2; R00). My
findings will provide a mechanistic understanding of habitual control normally, after stress, and in a model of
autism-associated genetic alteration. This will facilitate future work into the molecular and cellular mechanisms
of this phenomenon and ultimately serve my goal of improving treatment approaches for psychiatric conditions.
I will conduct my K99 training in the Wassum Lab at UCLA, with the guidance of a remarkable mentoring
team that has pioneered the open source miniscope technology. This environment will provide me with the
necessary intellectual and technical training I need to launch my independent research program studying the
mechanisms that allow environmental and genetic factors to modulate behavioral control strategies.

Public health relevance
Overreliance on habit strategies can be driven by environmental factors, like stress exposure, or genetic disruptions, and contributes to a range of psychiatric conditions, including autism. However, the mechanisms by which stress promotes habit is unknown. This project will identify the cell-type- and subregion-specific effects and interactions of stress and autism-associated genetic alteration on the striatal circuitry that controls habits.